Mechanisms of Bladder Cancer Development and Its Therapeutic Vulnerabilities to Preventive and Interventive Therapy.

Overall Summary
This P01 program project is focused on bladder cancer, a common human malignancy with significant morbidity
and mortality in the United States and across the world. The goal is to develop new and more effective therapies
for both early and advanced disease. This goal will be accomplished with molecular characterization of mucosal
field effects and their evolution to aggressive and therapy-resistant bladder cancer. Whole-organ mapping
studies will be complemented by molecular characterization of two mechanisms based on downregulation of
lysophosphatidic acid receptor 6 (LPAR6) and calcium-binding protein 39-like (CAB39L). These studies will be
supplemented by in-depth investigations of the role of luminal and basal phenotypic switch in the urothelium and
its role in therapeutic responses of bladder cancer cells. This P01 project has three well-defined goals: 1)
development of molecular profiles of bladder cancer evolution from field effects to clinically aggressive disease
on a whole-organ scale and investigating LPAR6 and CAB39L role, which contribute to bladder carcinogenesis
by dysregulating the urothelial differentiation program; 2) characterization of the role of luminal differentiation
program and its role in tumor formation; and 3) characterization of the role of luminal to basal plasticity in
response to interferon therapy. These goals will be accomplished in three projects. Project 1: Understanding
the Evolution of Bladder Cancer from Field Effects; Project 2: The Role of Nuclear Receptors Signaling in
Bladder Cancer; and Project 3: Identifying Molecular Vulnerabilities to Improve Interferon Gene Therapy in
Bladder Cancer. These projects will be supported by the Administrative, Pathology and Biostatistics and
Bioinformatics Cores. Collaborative studies by Projects 1 and 2 as well as by Projects 1 and 3 will focus on
the role of luminal to basal plasticity and dysregulated urothelial differentiation in therapeutic responses of
bladder cancer. Projects 1 and 2 will focus on the role of luminal dysregulation controlled by nuclear receptors
such as Pparg in the evolution of bladder cancer from mucosal field effects. Projects 1 and 3 will investigate the
expression pattern of IFN target genes in the evolution of bladder cancer from mucosal field effects as well as
the role of luminal to basal plasticity in therapeutic response. The work is proposed by a multi-institutional team
of scientists who have worked on bladder cancer for decades and have documented collaborations focused on
bladder cancer. The studies proposed in this P01 program project are highly promising options for early
detection, prevention, and treatment of bladder cancer.

Public health relevance
Overall Narrative This P01 proposal is focused on bladder cancer and proposes to develop new and more effective therapies for both early and advanced disease. It will investigate the mechanisms of therapy resistant and will identify novel therapeutic vulnerabilities of bladder cancer which will collectively address the majority of the population of patients effected with the disease. Successful completion of this project will provide detailed molecular characterization of early incipient phases of bladder carcinogenesis and in depth understanding of the role of luminal to basal phenotypic plasticity in therapeutic responses of bladder cancer.